Genetic and pharmacologic elimination of myotonia from myotonic dystrophy type 1

Project Summary:
Myotonic dystrophy type 1 (DM1) is the most common adult-onset muscular dystrophy that features prominent
muscular symptoms, including myotonia, weakness, and wasting, as well as a diverse array of extra-muscular
manifestations, including ocular cataracts, cardiac conduction abnormalities, and insulin resistance among
others. DM1 is an autosomal dominant disorder that has been linked to the CTG trinucleotide repeat (TNR)
expansion in the 3' UTR of the Dystrophia Myotonica Protein Kinase (DMPK) gene. DM1 patients possess
greater than 50 (CTG) repeats and transcribe toxic RNA products capable of sequestering RNA-binding proteins,
such as the Muscleblind-like (MBNL) family of splicing factors. This alters the available pool of splicing factors
leading to changes in the alternative splicing for more than 100 developmentally regulated transcripts. Overall,
these changes in splicing display a reversion back to embryonic patterns, with one example being the splicing
of transcripts for ClC-1, a voltage-gated chloride channel expressed in skeletal muscle. In DM1, there is
increased inclusion of exon 7a in Clcn1 transcripts, which causes a frameshift, premature termination codon,
and a non-functional ion channel. This yields decreased inhibitory chloride conductance that has been directly
linked to muscle hyperexcitability causing myotonia. In patients with DM1, the distribution of myotonia tends to
correlate with other muscular symptoms—including weakness and wasting—with the highest severity of these
symptoms localized to muscles of the distal extremities and oropharynx. This combined with evidence that
approximately one-fourth of the expression level changes of transcripts in myofibers could be due to myotonia
and not toxic-RNA has led to the hypothesis that myotonia plays a central role in driving the other skeletal muscle
pathology in DM1. To investigate this, we developed a novel mouse line (ClC-1∆E7a/∆E7a) resistant to myotonia
caused by the aberrant inclusion of E7a to eliminate myotonia from models of DM1. We will cross this novel line
with the Mbnl1-/- and Mbnl1-/-/Mbnl2-/+ mouse models of DM1 to eliminate myotonia from these models and
compare the changes in muscle physiology both in vitro (e.g., force contraction) and in vivo (e.g., grip strength),
histopathology (e.g., central nucleation, fiber-type distribution), and genetic regulation (RNAseq) between
myotonic and non-myotonic progeny. Thus far, we have successfully eliminated myotonia in Mbnl1-/-/ClC-1∆E7a
mice and have observed significant histological and splicing differences compared to myotonic Mbnl1-/-/ClC-1+/+
mice, with the non-myotonic mice featuring phenotypes closer to wild-type. Then, we will replicate these studies
with long-term anti-myotonic treatment of DM1 model mice with ranolazine with the goal that this could represent
a myo-protective approach to aid DM1 patients.

Public health relevance
Project Narrative: This proposal aims to investigate the role myotonia plays in driving the myopathy in myotonic dystrophy type 1 (DM1), and thus how anti-myotonic therapy could provide long-term myo-protective benefit to DM1 patients. Classically, myotonia and muscle hyper-excitability seen in DM1 are thought to be just symptoms of the disease; however, based on evidence from isolated models of myotonia, we hypothesize that myotonia could play a central role in causing or exacerbating skeletal muscle histopathological features and dysfunction observed in DM1 patients.